EFFECT OF PANCREATIC ENZYMES ON ZINC ABSORPTION IN CYSTIC FIBROSIS

This study will test the hypothesis that pancreatic enzyme replacement therapy in cystic fibrosis will result in improved fractional absorption of zinc.